2023 Eye Movements GRC & GRS

PROJECT SUMMARY/ABSTRACT
This proposal requests partial support for a unique international meeting on eye movement mechanisms,
disorders, and applications in the Gordon Research Conference series to be held July 9-14, 2023 at Mount
Holyoke College in South Hadley, Massachusetts, preceded by a Gordon Research Seminar organized and
hosted by and for trainees to be held July 8-9. The long-term goal of the conference series is to increase our
understanding of the structure and function of the eye, orbit, and neural circuits and of the characteristics of
eye movements in visual behavior in health and disease with the ultimate goal of more effectively diagnosing
and treating disorders of ocular motility, gaze control, and vision. The specific goal of the 2023 meeting is to
assemble a range of expertise and investigation that spans the remarkably broad intellectual landscape of our
field –- from muscles to nerves, from motor control to visual perception, from behavior to neurophysiology, from
disruptive strabismus to sophisticated coordination of vision and action. The specific aims of this meeting are to
convene 39 speakers and discussion leaders with approximately 140 participants for a five-day meeting in a
secluded setting. The program will have 9 sessions on basic topics including the development of extraocular
muscles, brainstem mechanisms of eye movement control, the organization of free-viewing behavior,
oculomotor exploration during navigation, transformations across different reference frames, decoding the
contents of fixations, and brainstem decision mechanisms. Four poster sessions will facilitate scientific
exchange and mentoring among participants. A Power Hour will provide an opportunity to support the
professional growth of women and under-represented minorities. In size and intensity, the Eye Movements
Gordon Research Conference is significant in our field for its ability to disseminate the latest scientific
advances, foster productive new insights and collaborations, stimulate interest in eye movement research
among young investigators, and increase the diversity of the research workforce, all with the ultimate goal of
accelerating the delivery of desperately needed new therapies to people with disorders of ocular motility, gaze
control, and visual behavior.

Public health relevance
Project Narrative The 2022 Myogenesis Gordon Research Conference entitled “Building, Maintaining, and Regenerating Muscle” will bring together expert speakers to educate and exchange information on the latest conceptual advances in skeletal muscle research. Topics to be covered include Building and maintaining skeletal muscle, Satellite cells and regeneration, The complexity of skeletal muscle architecture, Extrinsic regulation of the muscle microenvironment, Intrinsic signaling in muscle cells, Epigenetic, transcriptional, and post-transcriptional regulation of myogenesis, Cellular and molecular mechanisms of muscular diseases. The health relatedness of this application comes from the information disseminated by our speakers which will be used to advance our understanding of mechanisms regulating muscle health.